Improving Clinical trial Education, Recruitment, and Enrollment at CTSA Hubs (I-CERCH)

This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to understand the basis of pain and enhance clinical pain management.

Public health relevance
PUBLIC HEALTH RELEVANCE: A recent study showed that nearly 1 in 5 clinical trials ended early due to failure to enroll adequate numbers of study participants, or ended with less than 85% of the planned number of study participants. Ultimately, the challenge to recruiting for clinical trials slows the speed with which new treatments reach patients. We propose to provide solutions to recruitment challenges through innovative electronic health record-based tools, community engagement resources, and study-specific recruitment support that will enable researchers to implement recruitment strategies to meet their recruitment goals. Our center will be led jointly by Drs. Paul Harris and Consuelo Wilkins who will oversee an experienced, multi-disciplinary team to provide this much-needed support for clinical trial recruitment, enrollment, and retention at CTSA Hubs.